Drivers of Human Insulin Resistance and Sex-specific Alterations

Project Summary/Abstract
Insulin resistance is a major risk factor in the development of type 2 diabetes (T2D) and is also present in one-
quarter of the general population in a sex-dependent manner, which predisposes these individuals to the
development of T2D. The molecular determinants underlying insulin resistance and sex-specific impact remain
elusive. MS-based global phosphoproteomics using myoblasts derived from induced pluripotent stem cells
(iMyos) taken from insulin sensitive (I-Sen) and insulin resistant (I-Res) individuals showed a large network of
dysregulated phosphorylations linked to differences in insulin sensitivity. In addition, transcriptomic and
proteomic analyses of these cells revealed many genes differentially regulated by insulin resistance. While many
alterations were observed in cells of both sexes, I also identified many changes at the phosphoproteome,
proteome, and gene expression level that were modified by the sex of the patient. Preliminary analysis suggests
that DNA methylation may contribute to the sex-specific gene expression differences, but its role in insulin
resistance changes remains unclear. Based on these findings and the importance of insulin resistance in the
development of T2D, the overall goal of the grant is to identify the primary drivers of altered insulin signaling and
impaired glucose uptake ability in insulin resistance. To achieve this goal, the research aims are to identify the
upstream regulators of insulin resistance including Identifying the kinases driving the altered phosphorylation in
insulin resistance and identifying the drivers of defective glucose uptake using an unbiased CRISPR screening
approach. Phosphoproteome based Kinome analysis will be performed to determine how the kinase based
signaling alterations are related to changes in insulin resistance and cellular metabolism. A loss-of-function
genome-wide unbiased CRISPR screen will be performed to identify which genes/proteins and/or potential
kinases contribute to impaired glucose uptake characteristic of insulin resistance. This research proposal will
identify primary drivers of insulin resistance and provide mechanistic insights into different risks of developing
metabolic diseases between men and women. In addition to research work, training and career development
objectives will also be accomplished during the K01 career development award, including expanding knowledge
in metabolism and diabetes research, developing proficiency in computational analysis of sequencing data, and
developing leadership and professional skills. The training environment at Joslin Diabetes Center is phenomenal,
given that Joslin has been a preeminent center for diabetes research for over 110 years and the mentor, Dr. C.
Ronald Kahn, is an internationally recognized investigator in the field of diabetes research. I have an integrative
and multidisciplinary training opportunity to receive intellectual and career development advice.

Public health relevance
Project Narrative Insulin resistance is present in one-quarter of the general population, predisposing them to a wide range of diseases. Using global phosphoproteomics and RNA Sequencing of iPSC-derived myoblasts, we aimed to identify cell intrinsic determinants of insulin resistance and demonstrated a network of altered protein phosphorylation and gene expression in insulin resistance along with a major effect of donor sex. This proposal aims to uncover upstream regulators of underlying defects in insulin resistance and sex-specific signatures to improve our understanding of disease progression and how the sex of the cell donor can modify these alterations.